Patient-Oriented Research of Liver Disease

DESCRIPTION (provided by applicant): This competing renewal application is submitted for receiving continued funding to support protected time for Dr. Chalasani such that he can continue to provide mentorship for the new and junior investigators and to continue his own patient-oriented research. Dr. Chalasani has a proven track record in patient-oriented research with extensive publication record (more than 110 peer-reviewed publications, 11 text book chapters, 65 abstracts, 13 editorials/invited commentaries) and considerable extramural funding. He has successful record in mentoring junior investigators of various stages belonging to different disciplines. If funded, this award will continue to protect his time and help him sustain the momentum and productivity he has generated and achieve his mentorship and research goals. His research goals are to continue to conduct clinical and translational investigations in nonalcoholic steatohepatitis, drug induced liver injury and the relationship between cytochrome P450 enzymes (CYPs) and liver disease. His mentorship goals are to mentor suitable candidates of varying stages into taking up patient oriented liver disease research in a structured and sustained fashion and to develop them into independent and committed hepatology clinical investigators. His own funded research program will serve as the platform for providing this mentorship and he will leverage extensive institutional resources for research training of his mentees. His currently funded research program includes: (1) IU Clinical Center for the NASH Clinical Research Network (U01), (2) IU Clinical Center for the Drug Induced Liver Injury Network (U01), (3) Pathogenesis of Non- alcoholic steatohepatitis (R01). In addition he provides examples of several other ancillary and two proof-of principle clinical studies available for mentorship purposes. The sources for the candidates to be mentored by Dr. Chalasani include adult and pediatric GI fellows and junior faculty, Clinical Pharmacology fellows and pre-and postdoctoral trainees. His mentoring plans are (1) to provide methodological and content assistance to the trainees, (2) to provide guidance related to regulatory and compliance aspects of the patient-oriented research, (3) to provide protocol-specific opportunities for the trainees to get directly involved in patient-oriented research, (4) to provide on-and off-campus learning resources to enhance their ability to conduct patient-oriented research, and (5) to provide assistance with grant submission for intra- and extramural funding and publication of their research findings.

Public health relevance
PUBLIC HEALTH RELEVANCE: This K24 competing renewal application is being submitted by Dr. Chalasani for receiving funding support for mentoring young investigators and for research. Dr. Chalasani has received initial K24 award in 2005 and he has been successful in conducting research and in providing mentorship for junior investigators. His research is patient-oriented and is focused on nonalcoholic fatty liver and drug induced liver injury. These two illnesses are of major public health significance. PROJECT NARRATIVE This K24 competing renewal application is being submitted by Dr. Chalasani for receiving funding support for mentoring young investigators and for research. Dr. Chalasani has received initial K24 award in 2005 and he has been successful in conducting research and in providing mentorship for junior investigators. His research is patient-oriented and is focused on nonalcoholic fatty liver and drug induced liver injury. These two illnesses are of major public health significance. __SpecificAimsTextDelimiter__ The K24 Program Announcement outlines that research projects with ongoing federal funding following NIH peer review do not need to be described in detail. Thus, we will summarize our specific aims in this section and will outline various mentorship opportunities that they provide. The incidence of NASH is increasing in the United States but its pathogenesis is not well understood. Animal models of dietary liver injury showed that cytochrome P450 enzymes (CYP2E1 and possibly CYP4A) may play an important role in the pathogenesis of NASH. Recent human studies have shown that CYP2E1 activity is higher in patients with NASH compared to controls; however, the determinants and the role of elevated CYP2E1 activity (and CYP4A11) in the pathogenesis of human NASH are not known. We hypothesize that hepatic CYP2E1 plays an important role in the pathogenesis of human NASH, and we will conduct the following studies to investigate it role in the pathogenesis of NASH. Specific Aim # 1: Although studies have shown that patients with NASH have higher CYP2E1 activity than patients without liver disease, it is not clear if patients with NASH have higher CYP2E1 activity than those with steatosis alone. Thus, it is not known if CYP2E1 plays a role in the pathogenesis of NASH as a first (normal to steatosis) or a second hit (steatosis to steatohepatitis). CYP4A11 is a microsomal enzyme involved in the ω-oxidation of very long-chain fatty acids and its activation can lead to oxidative stress. It has been suggested that CYP4A enzymes may play a role in the pathogenesis of NASH but human studies are lacking. We hypothesize that CYP2E1 plays a role in the pathogenesis of NASH as a second hit and we will test this hypothesis by comparing hepatic CYP2E1 activity in patients with NASH and age, gender and BMI matched patients with steatosis and age and gender matched lean controls with normal hepatic histology. Secondary objectives are (a) to characterize the relationship between CYP2E1 activity and markers of oxidative stress, hepatic fibrosis and fibrogenesis, (b) to characterize the activity of hepatic CYP4A11 activity in patients with NASH and steatosis alone as compared to normal liver histology and (c) to characterize the PPAR protein content and mRNA expression in patients with NASH and steatosis alone as compared to normal liver histology. Specific Aim # 2: We have recently shown that hepatic CYP2E1 activity is significantly higher in patients with NASH compared to age, gender, and BMI matched controls, and that hepatic CYP2E1 activity correlated with measures of insulin resistance. We hypothesize that insulin resistance plays an important role in the pathogenesis of increased CYP2E1 activity in human NASH, and its reversal by administering rosiglitazone (insulin sensitizer) will lower CYP2E1 activity. To address this hypothesis, we will measure the hepatic CYP2E1 activity using chlorzoxazone as an in-vivo probe and the levels of serum and urinary markers of lipid peroxidation before and after the administration of rosiglitazone for 16 wks. Specific Aim # 3: CYP2E1 is an important source of oxidative stress and lipid peroxidation in the animal models of NASH. It has been shown that CYP2E1 activity is higher in patients with NASH compared to matched controls with no liver disease. However, the role of CYP2E1 as a source of oxidative stress and lipid peroxidation in humans with NASH has not been studied. We hypothesize that CYP2E1 is an important source of oxidative stress and lipid peroxidation in humans with NASH, and the degree of lipid peroxidation would be significantly lowered upon inhibiting the hepatic CYP2E1 activity in-vivo. To test this hypothesis, we will measure the hepatic CYP2E1 activity and serum and urinary markers of lipid peroxidation before and after administering a potent mechanistic CYP2E1 inhibitor (disulfiram) in patients with NASH and well-matched controls. Additionally, the effect of shortterm CYP2E1 inhibition on insulin resistance and adipokines and cytokines will be examined. Specific Aims Page 77 Principal Investigator/Program Director (Last, first, middle): Chalasani, Naga Specific Aim # 4: NASH is common in pediatric population but recent data show that it is histologically different than in adults. Unlike in adults where the inflammation and fibrosis are predominantly seen in zone III, the inflammation and fibrosis are portal-area based in children. This raises the possibility that different pathogenic mechanisms may be operating in pediatric NASH. Studies have shown that hepatic CYP2E1 activity is increased in adults with NASH. However, characteristics of CYP2E1 in children with NASH are not known. We hypothesize that children with NASH have a significantly higher levels of hepatic CYP2E1 activity than the matched controls, and the hepatic CYP2E1 activity is related to the degree of insulin resistance and lipid peroxidation. In order to investigate this hypothesis, we will measure the hepatic CYP2E1 activity using chlorzoxazone as an in-vivo probe in children with NASH and obese and lean controls. Secondary objective is to characterize the relationship between CYP2E1 activity and anthropometry, measures of insulin resistance, serum ketones, serum lipids, cytokines and serum and urinary measures of lipid peroxidation.